Developmental Funds

DEVELOPMENTAL FUNDS – ABSTRACT
Developmental Funds at KCI provide an important and essential source of funds in support of the Cancer
Center’s investment in strategic initiatives. These initiatives are formalized through extensive planning and
evaluation processes. During the past funding period, CCSG Developmental Funds were used in two key areas;
1) the recruitment of a key investigator in a Program leadership role, and 2) support of strategic pilot projects.
CCSG funds were significantly augmented by institutional support to further recruitment efforts and provide funds
for pilot projects aligned with KCI’s strategic priorities. Specifically, during the current grant cycle (12/1/2015 to
11/30/2019), $214,813 of CCSG Developmental Funds was augmented by an additional $14.8 million of
institutional support to provide valuable support for 51 pilot projects consistent with the strategic vision of KCI
and the recruitment of 36 new faculty, including 11 early stage investigators. The completed pilot projects have
resulted in a five-fold return on investment measured by success in obtaining peer reviewed extramural funding.
Additionally, new faculty level scientists have published 226 peer reviewed articles, secured 59 grant awards,
and activated 129 clinical trials since their arrival.
CCSG Developmental Funds in the amount of $55,550 are requested to fund pilot projects in the five areas of
the Cancer Center’s focused future development. CCSG Developmental Funds, invested in pilot projects and
augmented with institutional funding, have successfully driven innovative research and have led to extramurally
funded projects over the course of the current grant cycle. This trend is expected to continue into the years to
come, as KCI pursues the goals established in the strategic plan and engages with community partners to
develop innovative projects that address the specific needs of the catchment area.